Neural and molecular mechanisms of glucosensation mediating food choice behavior

DESCRIPTION (provided by applicant): Due in part to the rise in the worldwide incidence of obesity and diabetes, the molecular mechanisms regulating feeding behavior have received much attention. However, despite the tremendous increases in our understanding of how food intake and metabolism are coordinated, very little is known about the neural circuits and genes underlying feeding. Furthermore, how signals from both metabolic (to replenish energy) and hedonic (for reward) feeding circuits are integrated to regulate food intake and food choice remain unclear. While much has been learned from mammalian model organisms, very few genes involved in feeding behavior and energy homeostasis have been identified because of the difficulty in performing genetic screens in these models. Thus, using a genetically amenable model organism such as the fruit fly provides an ideal strategy to complement mammalian research. During my postdoctoral studies I developed an assay to study food choice behavior in Drosophila and found that flies are equipped with a mechanism to detect the nutritional value of food independently of taste. Specifically, food-deprived flies prefer calorie-rich sugars to zero-calorie sweeteners. Through genetic and behavioral screens, I identified a conserved gene that is required for flies to make metabolic feeding choices. This gene, a candidate Drosophila Sodium-Glucose-Transporter (dSGLT) is expressed in a small subset neurons in the fly brain. My hypothesis is that dSGLT regulates food choice by monitoring glucose levels in the blood. Indeed, homologues of this gene expressed in the mammalian hypothalamus are thought to play an active role in responding to changing glucose levels by affecting the excitability of neurons, but their role in feeding is not known. As defects in neural sensing of glucose in the hypothalamus have been shown to play a role in the development of obesity and contribute to type-2 diabetes, it is of the utmost importance to better understand the molecular mechanism of glucosensation underlying feeding and metabolism. In this proposal I present a focused strategy to characterize the function of the fly candidate dSGLT in glucose-sensation and behavior. I will determine if dSGLT is a glucose sensor and how it confers glucosensing properties to the neurons that express it. I will analyze if the neural circuit expressing this gene is necessary and sufficient for the choice for metabolizable sugars, and how the dynamics of glucosensation in these neurons modulate food choice behavior. Finally, I will conduct two targeted genetic screens: one to identify other genes involved downstream of glucosensing in dSGLT neurons and the other to identify the neuropeptides and neuropeptide circuits downstream of SGLT neurons that mediate the effector mechanisms ultimately regulating food choice. These studies will provide insights into the molecular mechanisms of glucosensation and its role in feeding. They will also provide mammalian researchers with conserved genes to use as molecular and neurochemical markers in future studies of glucosensation, feeding, and disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neurons in the mammalian brain respond to changing concentration of extracellular glucose by varying their firing rates. This process, also known as glucose sensation is thought to play an important role in the regulation of sleep-wake cycles, metabolism, and feeding. In particular, defects in glucose-sensation in the hypothalamus play a role in obesity and the development of type-2 diabetes. The lack of specific molecular and neurochemical markers to identify subsets of glucosensing cells, and the absence of exhaustive studies, from behavior to physiology, has hindered our understanding on the role of glucosensing neurons in feeding and homeostasis. Because done in a genetically amenable model organism like the fruit fly, our studies will produce fundamental insights into the genes and circuits involved in glucosensation. Furthermore, thanks to the wealth of behavioral genetic tools available in Drosophila, the effect of these genes can be directly tested on behavior. Thus, we are confident that our studies will identify both genes involved directly in glucosensation and those downstream of it, like neuropeptides, that ultimately modulate feeding. Furthermore, if successful, the outlined research could provide targeted therapeutics to treat defects in glucosensation that are involved in obesity, diabetes or other metabolic diseases. (Note: The critiques below were prepared by the reviewers assigned to this application. These commentaries and criterion scores do not necessarily reflect the position of the authors at the close of the group discussion, nor the final majority opinion of the group, although reviewers are asked to amend their critiques and criteria scores if their position changed during the discussion. The resume and other initial sections of the summary statement are the authoritative representation of the final outcome of group discussion. If there is any discrepancy between the peer reviewers' commentaries and the priority/impact score on the face page of this summary statement, the priority/impact score should be considered the most accurate representation of the final outcome of the group discussion.) __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Animals modulate feeding behavior according to changes in internal energy levels. To do this, the brain must monitor and integrate metabolic information and regulate feeding behavior through the secretion of peptides and activation of neural pathways to peripheral organs. Blood glucose is one of the major indicators of the metabolic state of the body. Glucosensing neurons respond to varying levels of glucose in the blood by changing their firing rates, thereby transducing information about the internal energy state into behavioral and physiological responses. Defects in glucosensation can lead to obesity and diabetes. It is thus paramount to understand the molecular and cellular mechanisms of glucosensation. To date, most of the research on glucosensation has focused on brain slice recording from hypothalamic glucosensing neurons to describe glucose-responsive cells. However, despite significant advancements in our knowledge of this process, the lack of genetic and neurochemical markers for specific groups of glucosensing neurons has hindered our understanding of the behavioral and physiological effects of glucosensation. In this proposal I present a focused strategy that takes advantage of the powerful genetic, behavioral and imaging tools available in Drosophila to characterize the genes and molecular mechanisms involved in glucosensation. During my postdoctoral studies I developed an assay to study food choice behavior, and used it to screen for genes and neuropeptide circuits underlying the preference for calorie-rich sugars during food deprivation. I identified dSGLT-L1, a Drosophila Sodium-Glucose Transporter- like gene expressed in a sparse population of neurons, that when mutated causes a specific feeding defect. My hypothesis is that dSGLT-L1 neurons modulate feeding behavior in the fly by responding to changing levels of sugars in the hemolymph. To test this hypothesis I will probe the function of this gene and the neurons expressing it in food choice behavior and glucosensation (Aims 1 and 2) and address how dSGLT-L1 neurons relay information to downstream circuits for feeding regulation (Aim 3 and 4). Mentored K99 Phase. Describe the electrical and cellular properties of glucosensing neurons expressing dSGLT-L1 identified during my postdoctoral work. In achieving this goal, I will also learn to perform electrophysiological recordings and imaging experiments. Aim 1. Dissect the architecture of dSGLT-L1-expressing neurons and test their necessity and sufficiency in food choice behavior. dSGLT-L1 is expressed in the ellipsoid body of the fly central brain. Because different cell types are present in this structure, I will use cell-specific knockdown to identify in which subset of cells dSGLT-L1 is required for food choice behavior. I will then investigate if the neurons identified are necessary to mediate the choice for metabolizable sugars and probe if their activation is sufficient to drive sugar preference in flies. Aim 2. Determine the glucosesensing properties of SGLT-L1 in vitro and determine the effects of glucose levels on the activity of SGLT-L1 neurons in vivo. My hypothesis is that SGLT is a glucose sensor; however, its properties have not been characterized. I will use Xenopus oocytes to describe the channel properties of dSGLT-L1 in vitro. I will ask if dSGLT-L1 is a sugar transporter or a sugar-activated cation channel by measuring the transport kinetics of sugars in vitro. Predictions about the function of dSGLT-L1 from these experiments will be tested in vivo by measuring its effect on neuronal activity with the fluorescent calcium indicator GCaMP. Independent K00 Phase. Understand how glucosensation modulates feeding by identifying genetic pathways downstream of the glucose sensor and neuropeptide circuits downstream of dSGLT-L1 neurons. Aim 3. Identify genes and neurotransmitters involved in glucosensation in dSGLT-L1 neurons. I will dissect the effector mechanisms of dSGLT-L1-mediated glucosensation by knocking down candidate genes specifically in dSGLT-L1-neurons. GABA and Dopamine Receptor are expressed in subsets of glucosensing neurons in mammals. dSGLT-L1 neurons express also GABA and the Dopamine Receptor 1. I will investigate the role of these neurotransmitters in mediating glucosensation and food choice behavior. Aim 4. Identify the neuropeptides mediating food choice behavior in Drosophila. Neuropeptides released by glucosensing neurons are potent modulators of feeding in mammals. I will conduct a screen to identify conserved neuropeptides mediating the preference for calorie-rich sugars during starvation. Genes and circuits identified from these aims will provide insights on the role of glucosensation in feeding and obesity and provide mammalian researchers with markers to genetically label subsets of glucosensing cells.